Administrative Core

PROJECT SUMMARY/ABSTRACT
The purpose of the Administrative Core is to support the translational research objectives of the UCLA
SPORE in Prostate Cancer by serving as the organizational hub. The Core is responsible for the oversight of
our SPORE by providing scientific leadership and administration for the proposed translational research
projects, shared core resources, Developmental Research (DRP) and Career Enhancement Programs
(CEP). The overall Specific Aims are: 1) Organizational leadership for successful SPORE conduct; 2)
Oversight and administrative support for daily SPORE activities; 3) Scientific management of the SPORE,
including scientific review of projects and cores to ensure scientific goals are met; 4) Administration of the
DRP and CEP; 5) Responsibility for maintaining fiscal and budgetary functions; 6) Organization and conduct
of regular SPORE meetings and seminars, including the Annual UCLA SPORE in Prostate Cancer
Symposium, quarterly investigator meetings, attendance at NIH/NCI meetings and relevant workshops; 7)
Compliance with all UCLA, NCI, and Federal regulations and requirements including appropriate animal
subject approval maintenance, appropriate human subject approval maintenance, and minority inclusion
policy monitoring; 8) A Data/Resource Sharing Plan implemented by project and core investigators; 9)
Liaison service for SPORE investigators, collaborators, and committee members, including the External
Advisory Board (EAB), Internal Advisory Board (IAB), Executive Committee and Patient Advocacy Group,
and responsibility for communication and consultation with the NCl-TRP program officer and staff; 10)
Implement and monitor recommendations of the External Advisory Board, Internal Advisory Board,
Executive Committee, CEP and DRP committees within the SPORE. The Administrative Core is led by
Robert Reiter, MD, the SPORE principal investigator, who oversees all SPORE activities. The Core's co-
director is Owen Witte, MD. The Administration Core also includes expert personnel in general university
operations, grants administration, financial management, computer network support and general
administrative duties.

Public health relevance
PROJECT NARRATIVE Prostate cancer is a major cause of morbidity and mortality in the US. The Administrative core will support the research goals of the Prostate Cancer SPORE, which are to apply basic laboratory research to the goal of preventing, managing and curing all forms and stages of this disease. This will be accomplished through 4 major projects focused on critical unmet needs in this disease, pilot and developmental research programs, and core infrastructure support of research.